The role of microglia in Parkinson's disease cognitive and motor impairment

7. PROJECT SUMMARY/ABSTRACT
Parkinson’s disease (PD), PD-mild cognitive impairment (PD-MCI), and PD-dementia cause substantial loss of
quality of life and healthcare utilization. PD is a heterogeneous pathoetiological syndrome, and while individual
genetic subtypes are being targeted with gene-specific disease-modifying strategies, “sporadic” PD needs to
be slowed by targeting mechanisms common across many forms of PD. Multiple lines of evidence support
activation of microglia as a critical step in the cascade of events in PD onset and progression. While autopsy
studies show microglial proliferation and activation in end-stage disease, we need to better tools to evaluate
microglial proliferation and activation in vivo in order to explore a causal relationship between this process and
disease progression. So far, microglial state has been imaged indirectly with radiotracers binding the
mitochondrial Translocator Protein 18 kDa (TSPO), which can represent mitochondrial activation of any cause
and TSPO ligands have several major caveats that limit their use widely. We developed a microglial-specific
radioligand targeting the colony stimulating factor 1 receptor (CSF1R), [11C]CPPC, and preliminarily suggest a
correlation between its binding and motor and cognitive disease severity in patients with early PD. The
objective of this proposal is to better understand the relationship between [11C]CPPC binding and cognitive and
motor severity in PD and PD-MCI while exploring correlations with pathology biomarkers (α-synuclein, β-
amyloid, tau), peripheral immune function and [11C]CPPC. Aim 1 is to determine whether CSF1R density is
increased in PD patients with more advanced motor and cognitive dysfunction. We hypothesize that A)
persons with early PD will have higher [11C]CPPC binding in the brainstem, striatum, pallidum, and thalamus
than age-similar subjects with no known neurodegenerative or autoimmune disorders and within PD, those
with the highest two quartiles of motor disability will have higher [11C]CPPC binding than those below the
median and B) in persons with PD or PD-MCI, CSF1R density will inversely correlate with verbal fluency,
executive, and global cognitive dysfunction in regions known to be involved with cognitive dysfunction (frontal,
temporal, parietal, and anterior and posterior cingulate cortices). Aim 2 is to assess whether CSF1R binding
with [11C]CPPC is associated with peripheral blood markers of immune function and neurodegeneration that
correlate with inflammation and disease progression, respectively. We hypothesize that A) those with the
highest tertile of CSF1R binding in specific motor regions will have higher percentages of CD4+ non-regulatory
T-cells and higher neutrophil-to-lymphocyte ratio on spectral flow cytometry and unique single cell RNAseq
signatures in peripheral blood mononuclear cells, relative to those with the lowest tertile of regional CSF1R
binding and that B) [11C]CPPC binding in motor and cognitive regions will correlate with plasma markers of
neurodegeneration and cognitive impairment, including amyloid-β42/40 ratio, p-tau181, total tau, glial fibrillary
acidic protein, and neurofilament light chain while CSF1R will be highest in those with α-synuclein seeding.

Public health relevance
8. PROJECT NARRATIVE One mechanism thought to play a substantial role in the onset and progression of Parkinson’s disease is activation of the brain’s immune cells, called microglia, causing damage to the brain cells that underly normal motor and cognitive function. This study aims to determine whether a new type of brain PET scan shows increased microglial activity in persons with more significant motor and cognitive symptoms of Parkinson’s disease and explores how this correlates with existing biomarkers of neurodegeneration and immune system function. Successful completion of this study would help researchers develop new treatments to slow the progression of Parkinson’s disease by validating a tool to measure their impact on microglia and would motivate future clinical trials targeting the brain’s immune system to slow disease progression.